Determining the role of PARP14 in restricting HSV-1 replication

Project Summary
Herpes simplex virus 1 (HSV-1) infects 70-90% of the human population and causes significant diseases such
as blindness and life-threatening encephalitis, most notably in immunocompromised individuals. In contrast,
most infections of immunocompetent hosts are asymptomatic and result in viral latency. Limited disease in most
human hosts is likely the result of millions of years of co-evolution between HSV-1 and humans, due, in part, to
a wide variety of host restriction factors that limit early stages of HSV-1 replication. Understanding the
mechanisms used by humans to repress HSV-1 replication will help identify treatments that can mitigate severe
HSV-1 diseases, especially in immunocompromised hosts. In a screen designed to identify novel host proteins
that interact with the HSV-1 genome, 3 poly(ADP-ribose) polymerase (PARP) proteins were identified that bound
to HSV-1 DNA with high confidence: PARP1, PARP9, and PARP14. Interestingly, prior studies had also found
that these three PARP proteins were bound to HSV-1 genomic DNA, providing strong evidence that these PARP
proteins could impact the replication of HSV-1, even though there have been very few reports of PARPs
associated with HSV-1 replication. In addition, PARP14 has been evolving under positive selection, suggesting
that it is involved in host-virus conflict, and we recently demonstrated that it can restrict coronavirus replication.
Thus, the ability of HSV-1 to replicate in PARP14 knockout (KO) A549 cells was tested, and surprisingly PARP14
KO cells produced 1-2 logs more in viral yield assays and increased the plaquing efficiency ~2-logs higher
compared to WT A549 cells. These results support the central hypothesis that PARP14 binds to the HSV-1
genome early in infection, leading to significant repression of HSV-1 replication. The overall objective of this
application is to establish PARP14 as a novel host restriction factor and determine how it binds to the viral
genome and inhibits virus replication. These objectives will be achieved through the following specific aims: 1)
Establish PARP14 as a potent restriction factor for HSV-1 in cell culture and in mice; and 2) Determine how
PARP14 represses the HSV-1 replication cycle and define how it binds to the viral genome. In Aim 1 a set of
PARP14 knockdown/overexpressing cells and knockout mice will be used to determine if PARP14 restricts HSV-
1 replication in multiple cell culture models and in mice. In Aim 2 the stage of the viral lifecycle that is repressed
by PARP14 will be determined using classical virological techniques, then ChIP-seq and several PARP14
truncation mutants will be utilized to define how it interacts with the viral genome. This research is innovative
because PARP14 has not previously been described as an HSV-1 restriction factor. The proposed research is
significant because it will provide a potential mechanism by which PARP14 restricts HSV-1 replication. Results
from this study will lead to a greater understanding of how PARPs interact with DNA-containing viruses, which
can ultimately lead to the rational development of novel therapies to prevent or treat HSV-1 diseases.

Public health relevance
Project Narrative This project will examine functional interactions between viral and host factors in which a host protein restricts HSV-1 replication. Results from this study can be used to develop new therapies for preventing or treating herpetic diseases, which is in the confines of NIH’s mission to promote scientific discovery while enhancing human health.